NEONATAL JAUNDICE AS AN EARLY DIAGNOSTIC SIGN OF URINARY TRACT INFECT

The primary objective of this study is to determine the frequency and extent to which serum concentrations of four standard first-line antituberculous agents in HIV-infected subjects fall outside expected ranges (compared with both currently available literature ranges and newly derived expected ranges for this population).